P30 Center Core Grant for Vision Research

ABSTRACT
Animal Analysis Core
Vision research requires the use of various animal models to investigate the mechanisms of visual
development and degeneration, the pathogenesis of blinding infection and inflammation, and the efficacy of
vision-saving therapeutics. The Live Animal Imaging and Functional Analysis Core at the University of
Oklahoma Health Sciences Center is responsible for providing vision researchers with state-of-the-art
instrumentation in the physiology and function of vision in small animal models of development, degeneration,
infection, and inflammation. These Cores support vision research on 16 NEI-funded R01 grants and other
vision-related projects at OUHSC in two different locations within vivaria, which allows in/out privileges. More
than 40 ocular disease models and more than 70 genetically altered mouse lines are currently being analyzed
with electrophysiological, genotyping, functional analysis, microscopy, and other support equipment in
expanded research areas renovated specifically for this use. The instrumentation provided by this Core
includes electroretinography (in vivo and ex vivo), optical coherence tomography, fundoscopy, optokinetics,
laser photocoagulation, tonometry, indirect ophthalmoscopy, and slit lamp and biomicroscopic imaging.
Environmental housing also includes equipment for light damage, dark rearing, hypoxia/hyperoxia, controlled
humidity, and glaucoma models. Genotyping provides accurate data for breeding transgenic animals for vision
research. Our Systems Managers are highly skilled in training personnel, assisting with experiments and data
analysis, and maintaining core equipment to a quality standard. As such, this Core consolidates and provides
instrumentation and expertise which would otherwise be too expensive or logistically difficult for vision
researchers across campus to easily access. As in the previous funding period, this Core is motivated and
committed to providing an effective, efficient, user-friendly, and high-quality research environment for all vision
researchers at OUHSC.